Enhancing Melanoma TIL Efficacy with Multifactor mRNA-Mediated T Cell Reprogramming

Refer to Parent Grant

SUMMARY AND SPECIFIC AIMS OF PARENT GRANT (R21CA282629, PI: KATZ). Although T cell mediated
immune responses are critical for successful immunotherapy, T cells associated with malignant lesions are
typically dysfunctional and fail to control tumor growth. Treatment with tumor infiltrating lymphocytes (TIL) that
are isolated, activated, and expanded ex vivo has proven effective in some melanoma patient populations.
However, many patients do not respond, presumably due to one of several host immune factors. Current
understanding of TIL mechanism of action suggests both an early robust expansion of tumor-specific effector T
cells and transfer of less differentiated cells with long-term survival capacity are key to successful therapy.
Evidence for the former includes the need for high dose exogenous IL-2 at the time of TIL infusion, correlation
of response with a high frequency of effector T cells, and majority of tumor killing occurring early after the initiation
of therapy. Evidence for the latter is found in many pre-clinical experiments as well as clinical observations where
the presence of TILs from the central memory subset in the infusion product correlates with tumor regression.
Our overall goal is to improve TIL therapeutic efficacy through generation of TIL products with both the transient
ability to effectively immediately kill tumor cells and the long-term ability to persist and maintain durable antitumor responses. We have developed robust methods to reprogram TILs with mRNA-mediated gene therapy.
The use of our mRNA approach has the advantages of increased safety, high efficiency, rapid production, tightly
controlled expression levels, and simultaneous multi-factor reprogramming. In preliminary work, we developed
a system that increases mRNA lifespan by an order of magnitude. Our single cell analysis of patient TILs preand post-expansion has identified two specific pathways deficient in the expanded TIL product that likely
contribute to their poor immediate efficacy and absence of memory fate. Both will be augmented by TIL mRNA
reprogramming. By leveraging our multidisciplinary team and existing infrastructure, the knowledge gained from
this project will be quickly translatable into clinical trials to examine the efficacy of mRNA reprogramming of TIL
to improve treatment of patients with advanced melanoma. We will complete the following Specific Aims:
Aim 1. Determine the ability to enhance post-expansion TIL survival.
1.1. Increase TIL durability by expression of an anti-apoptotic protein with a novel long-lived (loli) mRNA
expression system.
1.2. Augment TIL efficacy by reprogramming with supportive cytokine mRNAs.
1.3. Analyze efficacy of TILs reprogrammed with survival and cytokine mRNAs in patient derived xenografts.
Hypothesis: TILs encounter a large bottleneck of elimination upon infusion as they adapt from ex vivo culture
conditions to the harsh tumor microenvironment. By reprogramming with survival mRNAs that have long-lived
expression, the total, diverse TIL population will be able to acclimate with amplified efficacy.
Aim 2. Define the ability to produce post-expansion central memory (TCM/SCM) TILs.
2.1. Stimulate TCM TILs through enhancing OX40-OX40L interactions.
2.2. Steer TIL phenotype to TSCM by expression of Notch1 ICD mRNA.
2.3. Analyze efficacy of TCM/SCM-guided TILs in patient derived xenografts.
Hypothesis: Although the TCM/SCM phenotype is important for improved immunotherapy outcomes, our preliminary
data support that post-expansion TILs are predominantly TEM (effector memory). However, we also find that
OX40L identifies small populations of TCM/SCM and that loss of TCM/SCM in post-expansion cells corresponds to loss
of Notch1 activating ligands. Augmenting these pathways may enrich for this desirable phenotype.

Public health relevance
Refer to Parent Grant